Genomic Technology Development for Diverse Populations

ABSTRACT: The human reference genome was derived from 20 people, with an individual contributing most
of the genetic information. This linear reference does not represent the structural variation of the human
population. Pan-genome projects have attempted to address this missing variation, but the use of pangenome
references for whole transcriptome RNA-sequencing analysis is not clear, nor is the impact this has on
transcriptome data from different racial/ genetic ancestry populations. Here we will perform a benchmarking
project, whereby we will compare RNA-sequencing mapping statistics from a cohort of RNA-seq data when
mapped/ aligned to various reference genome constructs including Grch38, the Telomere-to-telomere
reference genome (chm13), reference genomes obtained from the human pangenome research project, both
as individual genomes, and as a combined graphical reference, and finally de-novo assembled individual
reference genomes generated by long read sequencing.
The goal of this project is to understand the tradeoff of individualized references vs. population-based
references with respect to computational burden and mapping accuracy. We will specifically ask whether
populations with European vs. African genetic ancestry benefit from more personalized references. We
hypothesize that reference genomes with related ancestry composition will improve accuracy of RNA-
seq mapping and our estimation of gene function.
To test this hypothesis, we propose the following Specific Aims: SPECIFIC AIM ONE: Test the utility of
reference genomes by determining the differential metrics of short and long read RNA seq data aligned to the
GRCh38 reference genome and the T2T reference genome (CHM13). SPECIFIC AIM TWO: Determine utility of
prior ancestry estimation for identifying the appropriate pangenome reference to further improve quality of short
and long read RNA seq alignments, compared to the GRCh38 reference genome, across HPRC reference
genomes (currently 47). SPECIFIC AIM THREE: Measure the QC metrics of short and long -read RNA seq data
aligned to the GRCh38 reference genome compared to individualized reference genomes.
This project will provide training opportunities for faculty, post docs and students at MSM to enhance
workforce training in genomics. The implication of this project will help determine whether there is a benefit of
determining an individuals reference genome or using population based reference genomes enhances the
information available in RNA-seq datasets.

Public health relevance
NARRATIVE: This project will assess the improvement in RNA mapping accuracy when we move for using a common human reference genome to individual reference genomes. We will determine the tradeoff and benefits in terms of computational and data burden of personalized genomics.